Mechanism by Which the Bicaudal D2-Nuclear Pore Protein 358 Interaction Activates Microtubule-based Cargo Transport

Project Summary/Abstract
There are many cargo such as secretory vesicles, autophagosomes, and liquid droplets that are
bi-directionally transported along microtubules by the opposing motors cytoplasmic dynein and
kinesin. However, it is still unclear how these two biological motors collaborate to position the
cargo and achieve cellular functions. Impaired bidirectional transport leads to a variety of
neurodegenerative diseases, including Alzheimer's disease. Microtubule-associated protein
MAP7 and dynein cofactor Lis1 are two important proteins that play critical roles in cargo
transport. While MAP7 enhances the processive motion of kinesin, Lis1 relieves the auto-
inhibition of dynein. In this proposal, we aim to reconstitute the DDBE-K (dynein, dynactin, BicD,
Egl, kinesin) complex and observe its motion on microtubule tracks in the presence of both MAP7
and Lis1 using total internal reflection fluorescence (TIRF) microscopy. Given that MAP7 has the
ability to prolong the attachment of kinesin to microtubules and Lis1 prefers binding two dyneins,
we predict that MAP7 and Lis1 will play key roles in determining the direction of motion of the
complexes on microtubules. Using single-molecule assays, we will investigate whether the
adapter protein BicD not only functions as a linker between cargo and motor but also plays an
essential role in sensing cargo and motor binding. These proposed studies will provide novel
insights into the roles of dynein and cargo adapter proteins and contribute to our understanding
of how cytoplasmic dynein and kinesin work together to transport cargo bidirectionally on
microtubules.

Public health relevance
Project Narrative Kinesin and dynein are two opposite polarity motor proteins that transport intracellular cargo along the axons of neurons, but adapter proteins such as BicD associated with these motor proteins regulate their movement. Impaired intracellular cargo transport leads to various neurodegenerative diseases such as Alzheimer's disease, Parkinson's disease, ALS, etc. This proposal aims to investigate how these two opposite polarity motors transport cargo bidirectionally in the presence of the microtubule-associated protein MAP7 and the dynein activator Lis1.